Cellular, Biochemical and Molecular Sciences Training Program

Project Summary/Abstract
The Cellular, Biochemical, and Molecular Sciences (CBMS) Training Program at
Vanderbilt University provides a unique educational and training experience for a diverse
group of graduate students spanning multiple departments and disciplines in the School
of Medicine and the College of Arts and Science. The mission and objectives are to
train the next generation of scientific leaders in critical thinking, experimental skills, and
communication/teamwork skills necessary for productive careers in modern biomedical
sciences. Laboratory training and cutting-edge research remain the core of the program,
complemented by structured didactic training in each discipline, as well as ongoing
mentoring, training in Responsible Conduct in Research, Rigor and Reproducibility,
career counseling, and leadership and communication skills.
The CBMS Training Program serves a unique role in interdisciplinary graduate
training at Vanderbilt by embracing a large preceptor list that spans 11 different
departments and programs. We emphasize broad-based, basic, interdisciplinary
research encompassing labs that study a range of topics, complementing other training
programs at Vanderbilt that are more discipline specific. Our program promotes
intellectual exchange within the biomedical community at the intra- and inter-laboratory
levels. We conduct the only university-wide, weekly journal club providing high level
scientific presentations across disparate fields from leading researchers in each area.
Trainees also participate in dedicated sessions providing opportunities for oral research
presentations, responsible conduct in research, rigor and reproducibility, career training,
and two dedicated courses---Experimental Design, and Maximizing Your Potential:
Leading and Managing Organizations, Teams, and your Career.
Diversity is a major goal of the CBMS training program at Vanderbilt, not only
diversity among our trainees, but diversity among research areas pursued by each
trainee. Since no one knows with certainty which areas of modern biomedical science
will be required in the next 10 years, it is essential to educate a diverse set of future
researchers and leaders in a broad fashion so that they will be well positioned to
capitalize on new findings and poised to succeed in unforeseen areas.

Public health relevance
The Cellular, Biochemical, and Molecular Sciences (CBMS) Training Program provides a highly enriching, rigorous, interdisciplinary environment to train the next generation of scientists to identify and attack critical, basic-science questions in medicine and biology. Our established cadre of preceptors and programmatic activities foster trainee development leading to new approaches and technologies to address critical challenges at the cutting edge of biomedical science.